Investingating the mechanisms controlling Neisseria gonorrhoeae Type IV pilus dynamics

PROJECT SUMMARY
The Neisseria gonorrhoeae (the gonococcus or Gc) Type IV pilus (T4p) is a critical colonization
and virulence factor during pathogenesis. T4p are used to adhere to host cells and promote
colonization. T4p are dynamic structures made of pilin fibers that extend and retract from the
bacterial cell. Beyond host cell adhesion, T4p are involved in a variety of cellular processes
including DNA uptake, twitching motility, and resistance to antimicrobial agents. We previously
identified a novel component of the Gc T4p, TfpC. Our published data illustrated that TfpC is
required for full piliation, and piliation is restored in tfpC mutants lacking the PilT retraction ATPase.
There are eleven other such mutants in the Gc T4p. Here, we use genetic, biochemical, and
biophysical techniques to define how TfpC contributes to T4p dynamics and architecture. We
show that while TfpC is required for complete piliation of Gc, remaining pilus structures undergo
extension at rates similar to parental strains. However, retraction is slower in strains lacking tfpC.
Furthermore, we demonstrate that TfpC stability is dependent upon the PilQ secretin. We also
identify an important motif within the flexible, disordered, proline-rich region of TfpC that is
important for function or stability of TfpC. I hypothesize that TfpC interacts with the PilQ secretin
or other components of the T4p to support a subset of T4p. To test this hypothesis, I will 1)
determine if TfpC interacts with the PilQ secretin, 2) perform structure-function analyses of TfpC,
and 3) interrogating the mechanism underlying reduced piliation in twelve pilus mutants. The
proposed research is significant because it will define the previously uncharacterized TfpC protein
required for piliation and link its activity to other pilus components. It will also provide important
information for other species T4p systems and possibly some Type II secretion systems. These
studies expand our current understanding of T4p architecture as well as the components
governing mechanisms of extension and retraction, providing a foundation for future studies on
the T4p dynamics essential for colonization and virulence. Long-term, the proposed research
could provide new targets for treating gonorrhea infections.

Public health relevance
PROJECT NARRATIVE The Type IV pilus (T4p) is the major colonization and virulence factor of Neisseria gonorrhoeae (Gc), the causative agent of gonorrhea in humans. We recently identified a novel component of the T4p in Gc, TfpC, but we do not yet understand how specific components of the T4p, like TfpC and others, contribute to its function. In this proposal, we aim to define the function of TfpC and its relationship to other proteins within the T4p; thus, we will define how these molecular components work together to regulate T4p dynamics, which will assist in developing future drug targets for gonorrhea.